STRUCTURE OF THE SUBUNITS OF EUKARYOTIC CHROMOSOMES

We wish to continue our studies on the molecular architecture of eukaryotic chromosomes by addressing the following four major aims with regard to nucleosome structure: 1. Binding Sites on Nucleosomes. We wish: (a) to map the points of contact between HMG-17 and histone octamers when either the first or second HMG binding site is occupied on nucleosomes; (b) to determine the polarity of adjacent histone H1 molecules along polynucleosomes; and (c) to map the points of contact between H1 and the histone octamer at the second H1 binding site on nucleosomes. These studies will employ techniques of zero-length protein crosslinking and peptide mapping. 2. DNA Methylation and the Nucleosome. We wish: (a) to determine the positions of 5-methylcytosine along the path of nucleosomal DNA; (b) to map the locations of methyl groups at higher levels of chromatin organization; and (c) to determine if a fraction of methylated DNA is organized in Z-form in isolated nuclei. Immunologic, radiochemical, and electron microscopic techniques will be employed. 3. Unusual Histone H2A Variants. We wish: (a) to determine the complete amino acid sequence of H2A.Z; and (b) to study the in vitro role of this protein in histone octamer formation. Protein chemistry and nucleosome reconstitution techniques will be used. 4. DNase I Hypersensitive Sites. We wish to identify, by in vitro mutagenesis, the in vivo base sequence determinants of the hypersensitive sites of a yeast heat shock gene. Standard procedures of recombinant DNA technology will be employed in conjunction with mapping hypersensitive sites by the indirect end labeling procedure.